Pregnane X receptor (PXR)-activating gut bacterial metabolites

The gut microbiota modulates human health and disease often via the production of small molecule
metabolites; however, the identities of the majority of gut microbial metabolites and their biological actions
remain largely unknown. Pregnane X receptor (PXR) is a ligand-activated transcription factor that is activated
by structurally diverse chemicals. PXR regulates the expression of genes encoding drug-metabolizing
enzymes including cytochrome P450 3A4 (CYP3A4). Additionally, PXR in the intestine and liver has been
implicated in the maintenance of gut barrier and immune functions as well as energy homeostasis.
Accumulating evidence suggests that the gut microbiota produces PXR ligands. To date, few bacterial
metabolites have been reported as mouse or human PXR ligands, and systematic efforts to identify PXR-
activating, gut microbial metabolites have been lacking. This lack of knowledge constitutes a substantial gap in
defining how the gut microbiota alters human health and disease especially via PXR. The long-term goal of our
research is to identify and characterize factors mediating gut microbes-host interactions. The overall objective
of this application is to identify gut bacterial metabolites activating PXR, a ligand-activated transcription factor
with pleiotropic biological functions including the regulation of drug-metabolizing enzymes and the
maintenance of gut homeostasis. Our central hypothesis is that gut bacteria produce metabolites that activate
PXR. Our hypothesis is based on the following preliminary results: (1) In HepG2 cells overexpressing human
PXR (HepG2/hPXR), the organic extracts of mouse cecum contents significantly induced hPXR transactivation
of PXR target gene (i.e., CYP3A4) promoter, indicating the presence of hPXR activators among gut microbial
products. (2) A screening of 10 common human gut bacteria led to identification of Fusobacterium nucleatum
as a producer of hPXR activator(s); in HepG2/hPXR cells, the organic extracts of F. nucleatum culture
supernatants significantly induced hPXR transactivation of the CYP3A4 promoter. (3) We increased the yield of
the active metabolite from F. nucleatum by changing the growth media and obtained a proton NMR and high-
resolution mass spectrometry results of an active metabolite-enriched fraction. The results suggest that PXR-
activating metabolite(s) of F. nucleatum are likely novel compounds. Together, our data indicate that gut
bacteria produce as-yet-unknown metabolite(s) that activate PXR. Based our findings, we propose to (1)
identify gut bacteria-derived metabolites that promote hPXR transactivation of CYP3A4 expression and (2)
define genetic determinants for the production of hPXR activator(s) in F. nucleatum. Successful completion of
these studies will set the stage for future investigation, providing much-needed tool sets to investigate
underlying molecular mechanisms for how the gut microbiota modulates PXR activity. Together, these efforts
will enhance our understanding of how the gut microbiota controls host physiology.

Public health relevance
Humans carry trillions of microbes in the gut, but compounds produced by these microbes and how those compounds affect human bodies are poorly understood. We propose to study the compounds produced by gut microbes. The knowledge obtained from this study can help us better understand how gut microbes modulate human physiology.